Detailed Molecular Structures of Tear Film Lipid Layer for Improved Treatment of Dry Eye Syndrome

PROJECT SUMMARY
Dry eye syndrome (DES) afflicts over 7 million Americans. DES can cause chronic and severe symptoms, leading
to visual disturbances. DES is caused by instability of the precorneal tear film (PCTF) at the surface of the eye.
While it is known that the stability of the PCTF plays a central role in DES, there is rigorous debate about what
causes PCTF instability. The tear film lipid layer (TFLL) is central to the stability of tear films. The TFLL is an
extremely thin layer of ordered lipid molecules separating the PCTF from the air. Researchers have proposed
several functions for the TFLL, including but not limited to reducing tear, preventing the collapse of the tear layer,
and providing a layer of defense against pathogens. However, it is unclear how changes in TFLL composition,
thickness, and arrangement induce PCTF instability and thinning. Several competing hypotheses naturally lead
to different strategies for treating DES. Stimulation of tear production, modulation of glandular function, and
supplementation with externally applied lipid solutions are all possible treatment routes. However, questions
about the causes of DES are difficult to answer because of lack of a detailed molecular structure of the TFLL.
Because of the TFLL’s dynamic nature, common experimental techniques are incapable of providing high-
resolution structural detail about how molecules arrange in the TFLL at the air-lipid and lipid-water interfaces.
Instead, researchers use lower resolution methods to probe composition and structure, sometimes indirectly
through model chemical compounds. However, these low-resolution techniques provide ambiguous results,
because multiple related molecular arrangements can produce the same signal. Thus, there is not a one-to-one
correlation between experimental results and molecular structures. In this study, we will generate and validate a
physiochemical computational model of the TFLL which considers the energetics of the system, and which will
be used to rationalize experimental observations about TFLL structure, function, and properties. Recent
developments in computational power allow researchers to simulate the motion of up to millions of atoms over
timescales long enough to allow the prediction of physical properties with a method called molecular dynamics.
The model begins with a description of the inter- and intramolecular forces acting on the TFLL’s components. A
virtual box of atoms is generated with a hypothetical molecular arrangement. Using classical physics, forces
between molecules are translated into motion of all atoms, and simulated snapshots of atomic positions are
collected. Analysis of these snapshots and associated energies allows the calculation of theoretical properties
that can be matched to experimental data. A successful model will match experimentally observed behavior and
provide a well-supported hypothetical TFLL structure for researchers to use for further studies. If successful, the
model developed in this work can help provide evidence for or against prevailing and competing hypotheses
about the function of the TFLL and the underlying causes of DES. Ultimately, the knowledge gained in this study
can be applied to improved design of treatments and therapeutics for DES.

Public health relevance
PROJECT NARRATIVE This project aims to provide a high-resolution description of the tear film lipid layer which is a thin layer of oil-like molecules that separate tears on the surface of the eye from the ambient air. Physical and chemical properties of the tear film lipid layer have been implicated in the development of dry eye syndrome, which affects 7 million Americans. With an improved, high-resolution description of the tear film lipid layer, researchers can test competing hypotheses about structure, properties, and function of the lipid layer and its relationship to the development of dry eye syndrome.